PSYCHOPHYSICAL AND EP ASSESSMENT OF VISUAL PATHOLOGY

The long-term objective is to apply psychophysical and evoked potential techniques to improving diagnostic and monitoring procedures, and to elucidate the mechanisms of optic nerve and retinal diseases. Specific aims are as follows: (a) Ocular hypertension. Find the percentage of abnormalities detected by visual contrast fields and by our low-contrast letter charts that develop into glaucomatous field defects, and whether the contrast defects are reversible. (b) Multiple sclerosis and amblyopia. Use psychophysical and evoked potential measures of discrimination and sensitivity to spatial form to further define organically-caused distortions of vision, and relate these distortions to the functional organization and sructure of the central visual pathways. (c) Diabetes. Find to what extent retinal fluoroscopy findings correlate with the results of our low-contrast letter test. (d) Develop a technique for quantifying and grading low peripheral vision. Psychophysical procedures include contrast sensitivity measurements at many locations in the visual field, orientation discrimination and spatial frequency discrimination. Evoked potential techniques include recording nonlinear interactions between two sine-wave gratings so as to assess spatial frequency and orientation bandwidths.